From Metabolic Stress to Energy Enhancement: Unraveling Complex V Dimerization in Mitochondrial Disorders

Project Summary/Abstract:
Leigh syndrome (LS) is a neurometabolic syndrome characterized by severe and progressive regression, often
triggered by a variety of metabolic stressors. Despite LS represents the most frequent pediatric mitochondrial
disease, therapeutic options are limited and non-targeted. LS is associated with a wide array of genetic
defects, most converging on a common pathway leading to energy failure.
This proposal builds upon a recent breakthrough in our understanding of LS. USMG5 is a gene encoding a
small peptide associated with ATP synthase, the molecular rotor that converts protons to ATP. We described
pathogenic variants in USMG5 causing LS. Moreover, we demonstrated that in this subgroup of patients with
LS, the defect arises not from a dysfunction with the ATP synthase enzyme rather from the inability of such
enzyme to dimerize. Stemming from this groundbreaking discovery, this investigation seeks to move beyond
USMG5, and fill the gap present in current literature on the role of ATP synthase dimers in energy regulation
and adaptation to metabolic stress. The ultimate goal is to understand this mechanism and harness it to
ameliorate energy defect and provide preliminary data for a novel therapeutic approach for mitochondrial
patients. Our research strategy will employ primary human fibroblasts, tissues, and knockout cell lines to
replicate ATP synthase dimerization defects.
In Aim 1, we will explore the biology of dimerization defects. By resolving sub-organelle levels with cutting
edge techniques, we will investigate how inner mitochondrial structural abnormalities disrupt the protons`
gradient, leading to ATP synthesis failure. Aim 2 will study ATP synthase dimers function as the 'gears' of
energy production. The hypothesis is that ATP synthase dimerization allows mitochondria to match production
to demand by optimizing proton force. We will use an integrative approach, combining standard biochemistry
with innovative real-time in vivo imaging analysis, to assess cellular responses to various metabolic stressors
mirroring those observed in LS. Aim 3 explores the therapeutic potential of manipulating dimerization.
Preliminary investigations suggest promise in enhancing ATP synthase dimerization through genetic
overexpression, offering a potential strategy for a range of energy metabolism disorders.
This research marks a significant advancement in our understanding of the mitochondrial stress response,
holding substantial therapeutic potential. Beyond its clinical implications, this endeavor signifies a major
milestone in my journey as a physician-scientist. It will deepen my comprehension of mitochondrial physiology,
expand my experimental toolkit through collaboration with my advisors, and closely involve my mentors in
laying the foundation for my independent translational scientist career. The insights gained will serve as a
cornerstone for my future contributions to the field and a significant stride in advancing therapeutic approaches
for mitochondrial diseases.

Public health relevance
Project Narrative The proposed research focuses on Leigh syndrome (LS), a severe childhood mitochondrial disorder characterized by neurological regression and movement disorders. Building upon our prior discovery of the USMG5 gene's association with LS, we aim to elucidate the impact of ATP synthase dimerization defects on mitochondrial bioenergetics by investigating the effects of metabolic stressors and exploring strategies to enhance energy production with the aim to pave the way for a new therapeutic strategy for mitochondrial diseases.